Project 1

Project Summary
Understanding the spectrum of germline mutations underlying hereditary cancers has clear clinical implications,
and while mutations in at least four dozen genes have been associated with heritable cancers, the prevalence,
characteristics, and clinical implications of most of these genes have not been well described in African
Americans (AAs). Due to the lack of racial diversity in genetic databases, we and others have shown that AAs
have been shown to harbor a disproportionate number of variants of uncertain significance (VUS) compared to
whites. A VUS result has the potential to not only increase psychological burden but also exclude African
Americans from gene-specific cancer treatments and prevention interventions, further exacerbating existing
racial disparities in cancer incidence and survival. VUS reclassification is a time- and labor-intensive process.
The international efforts for VUS reclassification include aggregation of epidemiological and family data, as well
as evaluation of functional data applying molecular biology techniques to in vitro and in vivo systems.
Unfortunately, the variants most likely to be examined are those seen most frequently in populations of European
ancestry and there is limited throughput for evaluating the thousands of VUS that have been identified to date.
The overall goal of the study is to develop and implement an integrative approach for re-classifying VUS and
identifying novel pathogenic variants through targeted germline sequencing, familial segregation analyses, and
somatic mutation profiling of tumors. The specific aims of the project are to (1) quantify the prevalence of
pathogenic variants and VUS in AAs with breast, prostate, colorectal, endometrial, and other young onset
cancers in metropolitan Detroit, (2) characterize segregation patterns of VUS in these genes among family
members and evaluate in silico and RNA-based predictions of pathogenicity of these VUS, and (3) develop a
tumor expression- and somatic mutation-based classifier to predict breast and colorectal tumors with PVs versus
non-PVs in a DNA repair gene (homologous recombination or mismatch repair) to be used for VUS
reclassification. This approach represents a powerful tool for characterizing the clinical implications of VUS in
cancer susceptibility genes using population science approaches. We will leverage data and biospecimens from
the Detroit Research on Cancer Survivors (Detroit ROCS) cohort, a population-based study of AAs with cancer
within the Metropolitan Detroit Cancer Surveillance System (MDCSS) registry catchment area. This study is
impactful as it will as it will result in a robust approach for identifying clinically actionable variants among African
American families affected with cancer.

Public health relevance
Project Narrative Variants of uncertain significance (VUS) in known cancer susceptibility genes are more commonly identified in African Americans compared to whites, and there is a need for innovative approaches to characterizing potentially clinically actionable VUS. Identifying novel pathogenic mutations in known cancer susceptibility genes will improve our ability to provide targeted prevention and treatment options for African Americans with hereditary cancers, and defining the genomic landscape of cancer susceptibility in African Americans will improve identification of high-risk individuals who would benefit from enhanced surveillance and precision treatments.